Research Experience and Training Coordination Core

Project Summary. The RETCC has played a coordinating role in the success of ULSRC since its inception
in September 2017. By working closely with other NIEHS-supported training programs at
the UofL (T32ES011564; T35ES014559), the RETCC has developed a rich,
multidisciplinary, and comprehensive training program. In addition to the course work
and ‘on the bench’ training activities, RETCC routinely organizes participatory field trips
to the Lee’s Lane Superfund site to better understand and appreciate health concerns of
residents in the adjacent community of Riverside Gardens; facilitates the meeting of
trainees with regional Superfund site coordinators and officials and the Metro Louisville
Public Health and Wellness Department. Our training core in collaboration with
Superfund Research Centers at Duke University, University of Kentucky, and University
of Pennsylvania organized a trip to Washington, D.C. so trainees could attend a Science
and Policy Institute meeting that included interactions with congressional leaders and
their staff. Such activities have been instrumental in the well-rounded growth of our
trainees. Moreover, these trainees not only provide “the force that turns the wheel” but
also are the focus and hub of intellectual crosstalk and fertilization across projects,
cores, other SRCs and the National SRP. To date, ULSRC success is the product of our
trainees’ successes through their many accomplishments including publications,
presentations, awards, degrees, fellowships, interactions with community partners, and
environmental health sciences-related career opportunities. Thus, although we are proud
of our current success via integration of trainee activities across the ULSRC, we
continue to strive to build on these successes by implementing innovative and unifying
features into RETCC-directed activities that focus on fulfilling the goals and furthering
the success of our trainees.

Public health relevance
Relevance: The overall goal of the Research Experience and Training Coordination Core (RETCC) is to direct successful training of graduate students and post-doctoral fellows (designated ‘trainees’) in the University of Louisville Superfund Research Center (ULSRC). This includes scientific interdisciplinary training within defined ULSRC projects and cores as well as promoting development of a broad knowledge base and the skills needed to communicate and engage with relevant community partners, government liaisons and health-care professionals regarding the importance of environmental health sciences research in the Superfund Program.